Diagnostic aptamer reagents to develop multi-analyte blood test for pre-clinical, mild and moderate Alzheimer's disease

Diagnostic aptamer reagents to develop multi-analyte blood test for pre-clinical, mild and
moderate Alzheimer’s disease
Aptus Biosciences, LLC
Bharat Gawande
Summary
Today, 6.2 million Americans are living with Alzheimer’s disease (AD), resulting in $355 billion in annual
medical care costs. As the US population over age 65 grows, the number of Americans living with AD is expected
to increase to 12.7 million by 2050. AD is a slow progressing disease, and it may take up to 20 years before
symptoms are recognizable. While new treatments are emerging, that may help to control or modify the disease,
early detection using a simple blood test is critical to individuals with AD. Importantly, recent studies have shown
promising results with blood-based biomarkers that are specific for AD. However, there is clearly a lack of high
affinity reagents that can bind to these biomarkers and be used to develop sensitive and easily accessible blood
tests.
Aptus Biosciences will use modified aptamer selection technology, to create highly sensitive and specific
reagents that detect blood biomarkers of AD which cause neurofibrillary tangles (NFTs), a hallmark of AD. We
will deliver aptamer reagents developed from an improvised In Vitro selection method using hydrophobic
modified nucleotides that can bind to tau protein, and multiple isoforms of phosphorylated tau (p-tau) protein
with pico-molar affinity. Each targeted selection will generate aptamers that bind to various epitopes on specific
p-tau targets with picomolar affinity and that will be used to develop a simple bead-based aptamer sandwich
assay in which one aptamer will capture p-tau biomarker and other aptamer will result in a signal generation to
measure the plasma concentrations of these analytes. Our modified aptamer reagents are potentially better than
unmodified aptamers and large antibody-based reagents, which are not as sensitive or specific because of their
large size, low affinity, and cross-reactivity in multi-analyte assays. Specifically, we will use selections to create
modified aptamers that bind to specific validated phosphorylated isoforms of tau. In addition, we will develop a
simple bead-based multi-analyte aptamer sandwich assay to measure p-tau isoforms in plasma samples obtained
from cerebrospinal fluid (CSF) Aβ42 positive, AD-confirmed individuals and compare them with plasma samples
obtained from cognitively normal, Aβ42 negative individuals without AD.
If this Phase I grant is successful, in Phase II, we will optimize aptamer reagents to improve the sensitivity and
specificity of the assay, scale-up aptamer reagent production, develop a cloud-based algorithm using a training
sample set, and validate the assay using test samples to correctly identify early AD in a large cohort. The multi-
analyte aptamer-based assay will make it far superior to existing qualitative, invasive, and expensive diagnostic
tests. If successful, this simple blood test will enhance the lives of millions of Americans who are at high risk of
developing AD due to the ability of the test for early detection, thus resulting in early treatment interventions
and decreasing the huge economic burden to the healthcare system.

Public health relevance
Diagnostic aptamer reagents to develop multi-analyte blood test for pre-clinical, mild and moderate Alzheimer’s disease Aptus Biosciences, LLC Bharat Gawande Narrative Current diagnosis of Alzheimer’s disease (AD) is inadequate for the early detection of the disease resulting in a lost opportunity for treatment before disease progression becomes irreversible. Fortunately, disease modifying treatment options are now available, which increases urgent need for the early diagnosis. This project will result in reagents that will detect specific biomarkers of AD in a simple and easily accessible blood test, which will allow individuals to test for early signs of AD years before their symptoms become obvious, thus allowing early treatment, and dramatic reduction in the economic costs of AD on the health care system.